Community-Partnered Exploration of the Pain-Related Treatment Needs of First-Generation Immigrants

Abstract
The Tailored Retention and Engagement for Equitable Treatment of OUD and Pain (TREETOP) clinical
research center at the University of Pittsburgh was established to develop effective, equitable, and
sustainable interventions for chronic pain and opioid use disorder. Its goal is to improve treatment for
comorbid chronic pain and OUD, particularly among rural and Black communities which have been
disproportionately impacted by the opioid epidemic.
This supplement will engage previously unengaged communities within the TREETOP research program,
specifically non-English speaking first-generation immigrants from the Latine and Bhutanese
communities in the Pittsburgh region. It will accomplish this engagement through partnership with
community organizations, and interviews investigating the experience of pain and substance use
disorders in these communities; these data collection methods will also explore the use of any
treatment for or means of coping with pain among members of these communities, including substance
use, as well as examine any treatment and pain management needs they have. This data, as well as the
relationships built in collecting it, will form the basis of a community co-designed pilot project to address
pain in non-English speaking communities. The final output of the supplement will be a pilot grant
proposal submitted to TREETOP, as well as methods papers outlining lessons learned from the
community-engaged research process.

Public health relevance
Project Narrative This is a supplement to the Tailored Retention and Engagement for Equitable Treatment of OUD and Pain (TREETOP) clinical research center at the University of Pittsburgh, which was established to develop effective, equitable, and sustainable interventions for individuals with both chronic pain and substance use, particularly opioid use disorder (OUD). This supplement will expand TREETOP’s engagement efforts to Non-English Speaking (NES) immigrants in the Pittsburgh region, thus increasing TREETOP’s reach into additional communities. It will accomplish this by interviewing NES immigrants from two communities – Latine and Bhutanese – to better understand their pain and substance use treatment needs, and subsequently by co-designing pain and substance use disorder treatments which will be created and delivered in the Spanish and Nepali languages, ultimately resulting in a pilot grant to implement and test the treatments.